Transcriptional Mechanism underlying Neuronal Hyperexcitability in FXS

PROJECT SUMMARY/ABSTRACT
Fragile X syndrome (FXS) patients show multiple symptoms associated with neuronal, synaptic, and circuit
hyperexcitability, such as sensory hypersensitivity, anxiety, and seizures. Although multiple mechanisms have
been proposed to explain hyperexcitability in FXS, an effective treatment remains unavailable, indicating the
need for search for more specific therapeutic strategy. It is well accepted that exaggerated activity of Group 1
metabotropic glutamate receptors (Gp1 mGluRs) contributes in part to the hyperexcitability in FXS. Activation of
Gp1 mGluRs has been shown to lead to robust elevation of intrinsic excitability of hippocampal excitatory
neurons and seizure susceptibility in mice. Despite these observations, the molecular regulation and
mechanisms underlying elevated neuronal excitability following activation of Gp1 mGluRs have been complex
and remain unclear. To improve our understanding of Gp1 mGluR-associated neuronal hyperexcitability in FXS,
our preliminary observations led us to study the tumor suppressor p53. Our recent studies discovered that the
activity of tumor suppressor p53 is positively correlated with neuronal excitability in vitro and seizure susceptibility
in vivo. Because our data showed that activation of Gp1 mGluR leads to activation of p53, and the transcription
activity of p53 is basally elevated in the FXS mouse model, the Fmr1 KO mice, we hypothesize that activation of
Gp1 mGluR promotes neuronal intrinsic excitability in part through p53-dependent gene transcription, and
inhibition of p53 can ameliorate neuronal excitability defects in FXS. To test this hypothesis, we propose in Aim
1 to study the mechanism by which p53 contributes to Gp1 mGluR activation-induced elevation of neuronal
excitability. We will follow by pharmacologically or genetically inhibiting p53 in Aim 2 to determine whether the
hyperexcitability phenotypes in Fmr1 KO mice can be ameliorated. We expect our research as proposed will
provide a new aspect to our understanding of FXS. In addition, with the deep knowledge of p53 in the field of
cancer biology and our preliminary data identifying neuron-enriched target genes of p53, the proposed research
has the potential to introduce many new concepts into the design of future treatment for FXS.

Public health relevance
PROJECT NARRATIVE Neuronal and circuit hyperexcitability is a common abnormality observed in FXS patients and FXS disease models. While many mechanisms have been reported to contribute to such a deficit, an effective treatment remains unavailable, indicating the need for identifying more specific therapeutic strategy. In this exploratory application, we aim to investigate a novel and underdeveloped molecule, tumor suppressor p53, in neuronal and circuit hyperexcitability seen in FXS, with the intention of introducing new concepts for the future study and treatment of FXS.